Oral elafin formulation for intestinal fibrosis

Project Summary
Prolonged Crohn’s disease leads to intestinal fibrosis, which is difficult to prevent or treat. The surgical
resection may negatively impact a patient’s quality of life. Thus, new therapeutic approaches are
actively sought after. We have recently shown that intestinal expression of antimicrobial peptide and
protease inhibitor elafin is reduced in stricturing CD patients. Its potential protective effect in intestinal
fibrosis has never been reported in the literature. Our preliminary data showed that elafin-
overexpression inhibited preexisting colonic fibrosis in TNBS-mediated mice, Salmonella-infected
mice, and SAMP1/YitFc mice. We generated an orally active elafin-Eudragit formulation for potential
therapeutic applications. The elafin-Eudragit formulation reversed preexisting colonic fibrosis in
TNBS-treated mice. We also discovered that elafin inhibits collagen expression in the intestinal
fibroblasts by modulating several stricture-specific genes. We hypothesize that oral administration of
modified elafin may be useful for treating colitis-associated intestinal fibrosis by affecting a stricture-
specific pathway. We propose to (1) establish oral therapeutic regimens of modified elafin for treating
intestinal fibrosis in a mouse model of preexisting intestinal fibrosis and (2) determine the cathepsin S-
PAR2-miR205-ZEB1-mediated anti-fibrogenic mechanism of elafin in intestinal fibroblasts. The overall
impact of this study will produce a comprehensive assessment of optimized oral elafin delivery
approaches for intestinal fibrosis. This mechanistic study will reveal how and why elafin inhibits
intestinal fibrosis.

Public health relevance
Public health relevance: The orally active elafin-Eudragit formulation is effective, convenient, and safe for reversal of preexisting intestinal stricture. We propose to understand the therapeutic performance of elafin in animal models. If the results are positive, elafin may be a new therapeutic agent against colitis-associated intestinal fibrosis in the future.